Investigating the effects of VNS on central autonomic network and interoception

ABSTRACT
The principal source of visceral afferent information to the brain from the body is the vagus nerve. The
sympathetic and parasympathetic nervous systems are the main branches of the autonomic nervous system
(ANS), and they dynamically control the visceral functions to maintain body homeostasis. A hallmark of the ANS
is its ability to react to environmental challenges/stressors in order to properly respond to the metabolic demands
of the organism. Cervical vagus nerve stimulation (VNS) is reported to modulate ANS and in particular heart rate
variability (HRV) and baroreflexes. Yet the mechanisms by which these are achieved remain unknown.
Disentangling the direct VNS effects of efferent modulation versus a centrally mediated modulation via afferent
fibers is key. This Supplemental Project will investigate the functional connectivity patterns of interoception and
high-order brain regions as measured by cutting-edge brain functional neuroimaging methods. Most importantly,
it will study their relationship to spontaneous fluctuations in blood pressure and heart rate. The REVEAL Common
Study Protocol (CSP) hypothesizes that any VNS-induced changes in blood pressure will be via stimulation of
afferent (sensory) fibers in the vagus nerve. This study is an alternative to test this hypothesis and will provide
key mechanistic data that will complement discoveries from the CSP. By acquiring functional brain imaging before
and after VNS implant and most critically, in the moment activations in response to VNS, we can ascertain
whether this upstream central nervous system modulation is at the midbrain reflexive level or whether it involves
higher-order brain regions. Interleaved VNSfMRI will act as a window for in-the-moment direct effects of VNS on
brain activity and interoceptive processes. The cutting edge precision functional mapping will reliably map the
multimodal networks involved in interoception and allostasis.

Public health relevance
PROJECT NARRATIVE The proposed Research Evaluating Vagal Excitation and Anatomical Linkages (REVEAL) center aims to conduct groundbreaking research on the effect of vagal nerve stimulation (VNS) on four key autonomic systems: the autonomic nervous system, the cardiovascular system, the immune system, and metabolic system. This research will produce a first-in-the-world dataset that will be foundational for the development of VNS-based therapies for several maladies related to autonomic systems.